Genetics, Epigenetics, and Risk Prediction for Esophageal Adenocarcinoma

PROJECT SUMMARY/ABSTRACT
Esophageal adenocarcinoma (EAC) is one of the most lethal cancers, with a 5-year survival rate less than
20%. Incidence of EAC has risen sharply in the U.S. and other Western countries over the past four decades,
largely due to rising prevalence of two risk factors – gastroesophageal reflux disease and obesity. EAC
develops from Barrett’s esophagus (BE), a cancer precursor defined by a specialized columnar metaplasia of
the distal esophagus. Although BE follows an indolent course in most patients, 5-10% eventually progress to
cancer, and a sizable fraction of BE remain undetected in the population. A critical unmet need is to identify
individuals with high-risk BE who are most likely to develop EAC and thus benefit from screening and
endoscopic surveillance. Conversely, identifying the majority who are unlikely to progress will reduce risks and
costs associated with unnecessarily frequent surveillance. Biomarker-assisted risk stratification, however,
continues to be hindered by our limited understanding of the molecular pathways underlying early steps in the
development of EAC. In recent years, genome-wide association studies (GWAS) have identified ~20 novel
genetic susceptibility loci, yet most heritability remains unexplained, and only one SNP is linked specifically to
BE→EAC progression. The epigenome, an important interface between the environment and the genome, has
not been studied for its potential mediating roles in relation to genotypes, strong environmental risk factors and
progression to EAC. To address these gaps, overcome sample size limitations for a rare cancer, and invigorate
existing research efforts, newer molecular and statistical approaches are needed to systematically integrate
multi-omics data with established disease exposures. In this project we will conduct the most comprehensive
multi-omics study of BE, the key cancer precursor, profiling the transcriptome and methylome of 500 biopsies
from the NCI-funded Barrett’s and Esophageal Adenocarcinoma Consortium and Roswell Park Comprehensive
Cancer Center, and perform integrative analyses leveraging genotypes and environmental risk factors already
available through the largest GWAS meta-analysis for BE/EAC (n≈27,000). The goal is to identify new genetic
risk loci through eQTL mapping and transcriptome-wide association study (Aim 1), new epigenetic loci
mediating and predicting the risk of BE progression to EAC (Aim 2), and develop risk prediction models
integrating genome-wide polygenic risk score and environmental exposures (Aim 3). The unifying theme of the
three aims is development and implementation of innovative analytical strategies, leveraging transcriptome and
methylome data. Ultimately, genetics, epigenetics, and environmental exposures will be incorporated to identify
high-risk populations for tailored screening and surveillance, and prevent cancer development.

Public health relevance
PROJECT NARRATIVE This project integrates transcriptome and methylome of Barrett’s esophagus (BE), the key cancer precursor of esophageal adenocarcinoma (EAC), with existing genetic and environmental risk factor data in genome-wide association studies. The goal is to identify new genetic and epigenetic loci underlying susceptibility and develop prediction models for EAC. Findings are anticipated to aid in the identification of individuals who are at elevated risk of EAC and may benefit most from preventive interventions, ultimately helping to reduce the public health burden of this deadly cancer.